Leveraging Context-Specific eQTL to Inform BMD GWAS

PROJECT SUMMARY:
Osteoporosis, characterized by decreased bone mineral density (BMD) and increased fracture risk, is a serious
public health issue. Genome-wide association studies (GWASs) have identified hundreds of associations for
BMD; however, most of the specific genes driving these associations remain unknown. This project aims to
bridge this gap by leveraging context-specific expression quantitative trait loci (eQTLs) to identify the potential
causal genes underlying BMD-associated loci. The goal of this project is to use context-specific eQTL
discovery in mesenchymal lineage (CD45-) cells to identify potential causal genes and then use cutting-edge
CRISPR-based approaches to begin to understand how they impact cells of the mesenchymal lineage. In Aim
1, we will use single-cell and bulk RNA-sequencing of bone marrow-derived mesenchymal stem cells (MSCs)
cultured under osteogenic conditions, to map eQTLs that are active during osteogenic differentiation and in
response to osteogenic stimuli. We will then integrate context-specific eQTLs with BMD GWAS data through
colocalization and Mendelian Randomization analyses, pinpointing candidate genes likely responsible for BMD
associations. In Aim 2, we will functionally validate genes using targeted Perturb-seq and in vitro and in vivo
CRISPR-based inactivation/activation (CRISPRi/a) approaches. We will assess the role of these genes in
osteoblast function and bone formation. This work has the potential to uncover novel regulatory mechanisms in
bone biology and identify therapeutic targets to treat and prevent osteoporosis. Ultimately, this project will
provide important insights into how genetic variation influences context-specific gene expression and how this
impacts mesenchymal cell differentiation, BMD, and osteoporosis.

Public health relevance
PROJECT NARRATIVE: Osteoporosis is a major public health burden, and a condition characterized by decreased bone mineral density (BMD). Current estimates indicate that 12 million people suffer from osteoporosis in the U.S. Osteoporosis is largely influenced by genetics. This project seeks to identify specific genes influencing BMD and osteoporosis using an innovative systems genetics analysis. Successful completion of this project will identify new therapeutic targets for the treatment of osteoporosis.